Quantitative Viral Outgrowth Assay (QVOA) Service Resource

HIV-1 replication can be effectively suppressed in HIV infected patients using highly active antiretroviral therapy (HAART). However, despite effective suppressive therapy, HIV has been known to exist in a state of latency, with the best characterized latent reservoir being the resting memory CD4+ T cells. These resting cells produce HIV when their resting state is reversed following cellular activation. To achieve a cure for HIV disease, the latent reservoir of HIV needs to be identified and eliminated. In order to evaluate the effectiveness of these strategies at clearing the latent reservoir, a reproducible assay capable of quantifying latent HIV is crucial. The best characterized assay today is the QVOA (Quantitative Viral Outgrowth Assay), also known as IUPM assay (Infectious Units Per Million) performed on highly purified resting CD4+ T cells under conditions that reverse latency and induce replication of HIV. However, QVOA measurements require large volumes of blood, are expensive, tedious, and labor intensive and therefore not the assay of choice for many laboratories conducting HIV eradication research. NIAID has a requirement to provide the QVOA as a service to the HIV research community. This service will allow standardized QVOA measurements so that unbiased comparisons between different eradication strategies can be achieved. Widespread use of the assay will raise the standards for latent HIV detection and reduce the need for surrogate, less accurate assays, presently used by some laboratories.